Identifying novel targets for cancer using high throughput deformability screening

ABSTRACT
The goal of this research is to discover novel regulators of cellular deformability that block cancer cell spread; to
achieve this goal we will use a high throughput cell filtration platform that is unique to the Rowat Laboratory at
UCLA. While most treatments for high grade serous ovarian cancer (HGSOC) are initially effective in reducing
tumor growth and spread, cancer recurs in over 80% of ovarian cancer patients because cells become resistant
to common, platinum-resistant chemotherapy drugs. There is a critical need for new therapeutics to block the
spread of chemoresistant tumor cells. While much research focuses on characterizing the genetic and
biochemical differences in chemoresistance, our proposed research will establish a new paradigm for screening
in drug discovery. Our previous research demonstrates that platinum-resistant ovarian cancer cells are more
compliant, or more deformable, than their drug-sensitive counterparts. These drug-resistant cells also showed
characteristics of mesenchymal cells; epithelial-to-mesenchymal transition is implicated in disease progression.
Using the novel High Throughput Filtration (HTF) screening technology that we recently invented, we can
distinguish platinum-resistant and platinum-sensitive cells on the basis of their deformability. In the proposed
research, we will use our HTF technology to screen platinum-resistant cell lines against large libraries of small
molecules to identify novel compounds and targets that reverse the deformability of platinum-resistant cells to
levels of the drug-sensitive controls. We hypothesize that the altered mechanical phenotype (or ‘mechanotype’)
of platinum-resistant cancer cells is a hallmark feature that can be used to inform novel therapeutic strategies
for ovarian cancer. Specifically, we postulate that we can identify novel molecules and targets that modulate
cancer cell mechanotype by conducting a high throughput screen on the basis of cell deformability; the lead
candidates that we discover will cause platinum-resistant cancer cells to become stiffer and reduce cell invasion.
We will test this hypothesis through the following specific aims: 1) Identify molecules and targets with potential
for anti-cancer treatment strategies using deformability screening; we will validate using functional assays as
well as patient expression data and tumor microarrays. 2) Discover novel targets for anti-cancer therapeutics in
platinum-resistant cancer cells using an unbiased genome-wide CRISPR-Cas9 screen with cellular deformability
as a readout. Taken together, our findings could address the lack of treatment options for HGSOC. Ultimately
the compounds that we discover could be used in combination with platinum-based therapies to target platinum-
resistant cells and thereby prevent disease recurrence and improve patient outcome.

Public health relevance
PUBLIC HEALTH STATEMENT The primary goal of this research project is to discover novel therapeutic strategies for ovarian cancer by identifying mediators and regulators of cellular mechanics. To achieve this goal, we will use a novel screening platform. Findings should lead to new opportunities to control cancer and improve patient outcomes.